Next Generation Stealth Lipid for the Delivery of mRNA

Project Summary
This proposal will develop a lipid nanoparticle (LNP) with a proprietary polyethylene glycol (PEG) alternative as
a new PEG-free LNP for the delivery of mRNA payloads. This proposal is motivated by increasing concerns
surrounding anti-PEG antibodies, PEG allergies, and reduced effectiveness of PEGylated carriers of drugs and
vaccines. As severe PEG allergies are expected to escalate with increasing PEG exposure in the population,
the importance of addressing this issue is magnified, especially in light of the extensive clinical pipeline of more
than 150 PEG-LNP formulations under development for diverse therapeutic payloads. To address these
concerns, Gateway Bio has developed poly(oligoethylene glycol) methyl ether methacrylate (POEGMA), a next-
generation polymer that resembles PEG but is tailored to address the existing limitations of PEG. POEGMA
comprises a brush polymer structure with tri(ethylene glycol) side-chains along a poly(methyl methacrylate)
backbone. The high density of tri(ethylene glycol) side-chains fully maintains the stealth properties of PEG, but
this unique architecture also limits the number of consecutive ethylene glycol units to just 3 repeats, which
eliminates PEG antigenicity—the binding of pre-existing anti-PEG antibodies to POEGMA, and mitigates anti-
POEGMA immune reactions—the formation of new antibodies which recognize POEGMA. Prior studies have
demonstrated the promising attributes of POEGMA-modified biologics, including long circulation in blood,
elimination of antigenicity—recognition by anti-PEG antibodies, and minimal immunogenicity—the induction of
anti-POEGMA antibodies. In Preliminary Studies for this proposal, evaluation of POEGMA in an LNP—employing
a wild type SARS CoV-2 spike protein encoded mRNA payload as a case study—reveals superior antigen
expression of POEGMA-modified LNPs compared to their PEGylated counterparts in vitro, with both model and
therapeutically relevant mRNAs. This proposal builds upon these studies by further evaluating POEGMA LNPs
for in vitro stability, in vitro toxicity, in vivo efficacy, anti-PEG antigenicity, and anti-POEGMA immunogenicity.
We anticipate that POEGMA-LNPs will exhibit superior antigen expression of the mRNA payload and reduced
immunogenicity compared to a PEG-LNP control, and will thereby pave the way for the adoption of this
technology across the diverse spectrum of nucleic acid based LNP formulations—vaccines, drugs, and genomic
medicines—that are currently under development.
1

Public health relevance
Project Narrative There are increasing concerns surrounding anti-PEG antibodies, PEG allergies, and reduced effectiveness of PEGylated carriers of drugs and vaccines. To solve this problem, Gateway Bio has developed a next generation PEG-like polymer that avoids the problems of PEG. Herein, we propose to replace the PEG in the LNPs used for mRNA vaccines with this new PEG-like polymer to provide a vaccine that is safer and more effective. 2